Engineering ingestible nanosensors for breath-based detection of colorectal cancer

Project Summary/Abstract
Colorectal cancer is the second leading cause of cancer death in the United States, and early
detection is key to reducing the 53,000 deaths per year. Current screening relies on tests for fecal
biomarkers, which have good sensitivity for advanced-stage CRC but poor sensitivity for early-
stage CRC. For this reason, direct visualization of the colon via colonoscopy remains the gold
standard for early detection. However, the invasiveness of colonoscopy deters individuals from
completing regular recommended testing, and nearly 25% of cases are diagnosed when the
cancer has spread to distant sites resulting in a greater than 70% drop in 5-year survival rate.
Thus, there remains an outstanding need for non-invasive and sensitive diagnostic tests to
improve adherence to screening guidelines and, ultimately, improve the rate of early detection.
This proposal aims to develop ingestible nanosensors that are engineered to sense disease
activity in the intestine and produce amplified reporter signals in breath (i.e. synthetic breath
biomarkers) for early-stage CRC detection. More specifically, nanosensors will be designed to
sense the activity of particular enzymes in the intestinal mucosa that play significant roles in tumor
development. These include host enzymes that regulate growth and angiogenic factors and
remodel the extracellular matrix for tumor invasion as well as enzymes from the microbiome that
promote tumorigenesis through activation of genotoxic compounds. To harness intestinal enzyme
activities for breath-based CRC detection, a panel of nanosensors engineered to sense
orthogonal enzyme targets will be barcoded with volatile reporters of distinct mass for multiplexed
analysis. Nanosensors will be formulated for oral delivery, and after reaching the intestine, will
release reporters upon degradation by their enzyme targets. Liberated reporters will be exhaled
in a matter of minutes due to rapid volatile clearance mechanisms. Altogether, this will culminate
in a breath biomarker signature for CRC that is detectable by mass spectrometry. Ingestible
nanosensors will be tested in animal models of CRC, where enzyme-amplified breath signals may
drive sensitive tumor detection, and multiplexed breath signals are expected to facilitate highly
specific disease detection. Success of this platform technology would provide a path to
noninvasive, breath-based detection for a broad range of GI diseases and, thus, eliminate the
logistical barriers to early disease detection.

Public health relevance
Project Narrative Colorectal cancer is the second leading cause of cancer death in the United States, and early detection is key to reducing the 53,000 deaths per year. To improve early detection, non-invasive diagnostic tests are needed to improve adherence rates to screening guidelines. To address this need, we seek to enable breath-based detection of colorectal cancer by developing ingestible sensors that can detect disease activity in the intestine and release reporters that are exhaled for non-invasive detection in breath.